Associations between Perfluoroalkyl Substances (PFAS) Exposure and Aeroallergen Sensitization among Infants at High-Risk for Developing Asthma

PROJECT SUMMARY/ABSTRACT
Candidate: Dr. Medina Jackson-Browne, PhD is an environmental epidemiologist with primary research
interests in the role of early-life environmental chemical exposures on the immune and respiratory systems
in children. The goal of this proposal is to obtain training in the skills to build Dr. Jackson-Browne’s research
career in pediatric clinical research. We propose several initiatives to strengthen Dr. Jackson-Browne’s
career. Specifically, Dr. Jackson-Browne will gain new research skills and enhance her understanding of
1) the clinical trial process with Dr. Phipatanakul, MD, 2) train in early-childhood immune system
development and respiratory physiology and 3) translate this research and training to position her for a
future R01. To achieve this goal, she will obtain training in clinical trial design, database design and
management, and advanced biostatistical methods. This will be accomplished with formal coursework,
collaborative work, attendance at conferences, and guidance from established mentors/scientific advisors
with relevant expertise. The proposed research and training plan builds the foundation for an independent
research career that aims to address gaps in the understanding of timing and mechanism through which
environmental chemical exposure affect respiratory health in early childhood.
Research: Early-life exposure to environmental chemicals, particularly chemical’s known to bioaccumulate
in humans, is of increasing concern in the development of asthma in children. Aeroallergen sensitization
is a pivotal risk factor for developing persistent, progressive asthma throughout life and sensitized children
have a higher prevalence of early-life wheeze and poor lung function. These potential associations are
particularly relevant to populations with higher exposure to these chemicals and those at a higher risk for
developing and/or dying from complications from asthma such as Black and low-income urban children.
This proposal details a five-year plan to provide Dr. Jackson-Browne with the training and expertise to
address gaps in the understanding of the timing through which perfluoroalkyl substance (PFAS) exposures
may affect asthma development in children by leveraging infrastructure of an on-going pediatric clinical
trial of 2-3-year-old infants at high risk of developing asthma (PI, Dr. Wanda Phipatanakul, MD).
Environment: Dr. Jackson-Browne will be mentored by Dr. Phipatanakul, an expert in epidemiology,
clinical trials, and clinical investigation in asthma and allergic diseases. She has assembled an
extraordinary team of advisors, including Drs. Jessie Buckley, Stephanie Lovinsky-Desir and Suzanne
Dahlberg who have committed their time, resources, and expertise to facilitate Dr. Jackson-Browne’s
career development and successful completion of the proposed project. The academic environment
created Boston Children’s Hospital and their affiliates provides an ideal training environment specific to
her goals of achieving research independence.

Public health relevance
PROJECT NARRATIVE The prevention of asthma development in children is a pressing, unmet need of utmost priority. There is also a need to identify periods of susceptibility to persistent environmental chemical exposures in children. The proposed research will determine if perfluoroalkyl substance (PFAS) exposures are associated with aeroallergen sensitization, a known precursor to asthma development, in young children (aged 24-47 months) risk for developing asthma.